LI/NEI Repository Protocol

Data and samples will enter this protocol from terminated IRB-approved protocols under which all human participant enrollment and participation is complete including:  Protocol 04-EI-0065 (SCL31 Levy-Clarke)  Protocol 96-EI-0096 (HAT Nussenblatt)  Protocol 06-EI-0239 (Sarcoidosis Levy-Clarke)  Protocol 02-EI-0099 (Microarray Nussenblatt)  Protocol 05-EI-0178 (SITE Nussenblatt)  Protocol 05-EI-0208 (HAT/JIA Nussenblatt)  Protocol 00-EI-0204 (Uveitis ENT Nussenblatt)  Protocol 98-EI-0085 (Uveitis Screening Nussenblatt)  Protocol 04-EI-0260 (Uveitis Marker)  Protocol 06-EI-0046 (Anti-CD11 Nussenblatt)  Protocol 06-EI-0111 (AMDB1 Nussenblatt)  Protocol 09-EI-0191 (JakStat Sen)  Protocol 09-EI-0116 (SIRANU Sen)  Protocol 10-EI-0186 (MIME Sen)  Protocol 11-EI-0167 (JakStat 2 Sen)  Protocol 11-EI-0107 (MEXX Sen)  Protocol 10-EI-0191 (BOOTS Nussenblatt)  Protocol 10-EI-0040 (RAIR Sen)  Protocol 12-EI-0057 (ISAS Sen)